Targeted radionuclide therapy for tumor immunomodulation and enhancing immunotherapy response

Project Summary/Abstract
We aim to improve the cure rates for metastatic cancers. To achieve this we propose a combined modality
approach to stimulate and diversify an endogenous anti-tumor immune response at all tumor sites to recognize
and destroy tumor cells in a manner that will prevent recurrence and enable long-term cancer free survival.
Immune checkpoint inhibitors (ICI; e.g. anti-PD-L1), are a class of immunotherapies that modulate immune
tolerance of a tumor by blocking specific inhibitory receptor-ligand interactions on the surface of T cells and
thereby overcoming T cell inhibition or exhaustion. In patients with immunologically “hot” tumors, characterized
by a pre-existing but exhausted anti-tumor immune response, ICIs can restore efficacy to the anti-tumor immune
response, sometimes resulting in complete and durable tumor regression. However, ICIs have not shown clinical
benefit in the treatment of immunologically “cold” cancers that are characterized by low levels of T cell infiltrate
and low mutation burden resulting in few mutation-created neo-antigens. To overcome immunotherapy treatment
barriers posed by immunologically cold tumors, we propose to combine systemic delivery of ICIs with systemic
delivery of radiation by targeted radionuclide therapy (TRT). To date, nearly all approaches to combining
radiation and immunotherapy have used external beam radiotherapy (EBRT), which promotes tumor immune
cell infiltration through activation of type I interferon (IFN) responses. Administration of EBRT to multiple tumor
sites or to the whole body (to target radiographically occult or microscopic disease) would result in prohibitive
toxicity, including lymphopenia. TRT is a systemic method of delivering a therapeutic radionuclide to a tumor,
which poses an alternative option for delivery of immunomodulatory radiation to metastatic tumor sites without
causing immunosuppression. The Weichert lab at the University of Wisconsin-Madison has developed a novel
class of TRT, known as NM600, an alkylphosphocholine analog that is selectively taken up and retained in nearly
any tumor type in any location. Our broad hypothesis is that unique physical properties of radionuclides (e.g.
emission type, linear energy transfer, half-life, tissue range) differentially impact immunomodulation by TRT. In
this study, the immunomodulatory capacity of alpha- (225Ac) and beta- (90Y) particle emitting radionuclides will be
compared directly. In a project that builds upon the ongoing collaborative progress of the Morris and Weichert
labs, we will now determine the radionuclide-specific potency of combining TRT with immunotherapy to enhance
the immune response against immunologically cold tumors. In murine models, we will: 1) expand on preliminary
data showing potent synergy with the combination of TRT and ICI, 2) evaluate therapeutic mechanisms of TRT
and ICI using the intrinsic properties of 225Ac- and 90Y-NM600, focusing on type I IFN response activation and 3)
investigate potential enhanced tumor responses with the combination of two distinct radionuclides with ICI. The
insights and treatment regimens developed in these studies should enable rapid translation to clinical testing in
patients and potentially for any type of metastatic cancer.

Public health relevance
Project Narrative Cancer is increasingly becoming a larger public health burden, with rising incidence of many cancer types and rapidly rising treatment costs worldwide necessitating development of new, effective cancer therapies. We are developing a new approach, representing a dramatic shift in the treatment of metastatic cancer, utilizing immune responses to recognize and destroy cancer (known as immunotherapy) in combination with systemically administered radiation therapy, known as targeted radionuclide therapy (TRT). This grant application proposes experiments that will deepen our mechanistic understanding of the dynamic radionuclide-specific effects of TRT on tumor cells, immune cells, and anti-tumor immunity, with potential for the results to expand treatment options for metastatic cancers in the U.S. and abroad.